IN-VIVO RAT KIDNEY METABOLIC KINETICS OF PYRUVATE USING HYPERPOLARIZED 13C MRSI

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. With signal-to-noise ratio enhancements on the order of 10,000-fold, hyperpolarized MR spectroscopic imaging (MRSI) of metabolically active substrates allows the study of both the injected substrate and downstream metabolic products in vivo. Although hyperpolarized [1-13C]-pyruvate, in particular, has been used to demonstrate metabolic activities in various animal models, robust quantitation and metabolic modeling remain important areas of investigation. Enzyme saturation effects are routinely seen with commonly used doses of hyperpolarized [1-13C]-pyruvate, however most metrics proposed to date, including metabolite ratios, time-to-peak of metabolic products, or estimated exchange rate constants fail to capture these saturation effects. In addition, the widely used small flip-angle excitation approach doesn't correctly model the inflow of fresh downstream metabolites generated distal to the targeted slice, which is often a significant factor in vivo. To read about other projects ongoing at the Lucas Center, please visit http://rsl.stanford.edu/ (Lucas Annual Report and ISMRM 2011 Abstracts)